Administrative Core

Summary
The Administrative Core (AC) of the UNM CHANGES (Climate and Health Allied Network for Geospatial and
Environmental Science) Center is tasked with the ambitious objective of not only coordinating and leading the
center, but also creating integrative structural organization for two separate campuses: UNM Main and UNM
Health Sciences Center. The long-term goal of the UNM CHANGES is to become a national leader in Climate
Change and Human Health research, with a regional focus on solving issues impacting our vulnerable
communities. The goal of the present application is to establish a centralized and effective AC that provides
managerial, fiscal, and organizational support for the scientific objectives, mentoring activities for our junior
investigators, and coordinating activities and output for our cores and projects. The rationale for the AC is to
ensure the long-term success of the UNM CHANGES Center and begin the establishment of a cross-campus
model for the integration of research units needed to address the complexities of human health impacts of
climate change. This success extends beyond independent research projects and it requires effective and
integrated training, communication, organization and team science approaches that the AC will provide. The
Administrative Core, therefore, has three specific aims. Specific Aim 1 will be to provide scientific direction and
organizational support for the UNM CHANGES Center. The leadership of the AC will drive scientific objectives
and provide strategic planning as well as managerial and fiscal oversight. The AC will establish an External
Advisory Committee (EAC) of internationally recognized experts in biomedicine, cancer biology and toxicology
to ensure high productivity, innovation, and success of the Center. Additionally, through its advisory
committees and leadership team, the AC will provide vision for the strategic development of our Cores to
ensure that capabilities remain both state-of-the-art and tailored to the needs of our center members and
external partners. In Specific Aim 2, we will manage core facility utilization and data generation, storage,
analysis, and dissemination. The AC will provide coordination, management and evaluation to ensure that our
Center generates quality data that is publicly available. Establishing and executing a high-level data
infrastructure and management plan will ensure high quality research products, broad utilization of the Center’s
research output, and optimal information for dissemination and implementation. Lastly, in Specific Aim 3, we
will promote innovation and expansion of research on climate change and human health. To expand the
quality and impact of research related to climate change and to ensure sustainability of the Center, the AC will
advance 1) campus-wide, team science-focused pilot projects; 2) recruitment and mentoring of new PIs that
leverage the geospatial and data science resources to address broader impacts on human health; 3) high
profile seminars and remote engagement with local and regional healthcare providers as well as research
institutes, centers and departments; and 4) effective center evaluation strategies.